Prospective metabolomics investigation of gastric cancer risk in African Americans and European Whites with a low socioeconomic status

ABSTRACT
Gastric cancer is one of the most common and deadly cancers globally, accounting for over one million new
cancer diagnoses and 783,000 deaths in 2018. Infection of Helicobacter pylori (H. pylori) is the most important
risk factor and a necessary cause for non-cardia gastric cancer. While targeting high-risk populations who are
infected with H. pylori seems a compelling strategy for gastric cancer screening and prevention, a significant
concern not addressed is that only ~1 to 3% of the H. pylori infected individuals develop gastric cancer, indicating
that such strategy based on H. pylori status alone is insufficient, particularly among populations with a relatively
low prevalence of H. pylori infection. Thus, discovering and validating additional biomarkers, especially non-
invasive ones, are needed to facilitate the development of novel risk assessment tools for gastric cancer. The
human metabolome reflects endogenous responses and processes to exposures, including environmental and
lifestyle factors that are related to carcinogenesis. The use of advanced metabolomics techniques in prospective
population-based cohort studies have successfully identified both novel etiologic factors and risk biomarkers for
different cancers. However, few prior studies have focused on identifying novel risk biomarkers for gastric cancer
using metabolomics techniques, particularly in prospective design settings. We recently conducted the first
nested case-control study within two large prospective cohorts. Our study identified 5 metabolites associated
with risk of gastric cancer after correction for multiple comparisons and 13 additional metabolite candidates for
further investigations. These include metabolites related to vitamin B12 deficiency, green tea/coffee intake, and
two progestin steroids, representing a few biologically plausible mechanisms involved in gastric cancer etiology.
Herein, we propose to conduct a large prospective investigation within a newly formed international consortium
to validate these highly promising findings, as well as discovering novel risk biomarkers, using both untargeted
and targeted metabolomics approaches. Pre-diagnostic plasma samples and epidemiologic data including
demographics, lifestyle factors, and dietary intakes will be harmonized for >1,600 incident cases and about 2,000
matched controls from eight prospective cohorts. The proposed study will incorporate a rigorous two-stage
design to screen and validate circulating metabolite biomarkers for gastric cancer risk in Asians and Whites (Aim
1). We will further assess the generalizability of the validated biomarkers in Asian Americans, African Americans,
and Hispanics/Latinos as well as discover novel race-specific biomarkers in these populations for future
investigation (Aim 2). Finally, we will assess mediating effects of the identified metabolites on the associations
between known risk factors and gastric cancer to facilitate the understanding of involved biological mechanisms
(Aim 3). Through a series of rigorously designed research activities, fresh insights into mechanism of gastric
carcinogenesis and novel biomarkers for future development of risk assessment tools are expected.

Public health relevance
PROJECT NARRATIVE Gastric cancer remains an important health burden in the United States and worldwide, of which the etiology is not fully understood and effective biomarkers for risk assessment is still lacking. The advancement in metabolomics techniques provides new opportunities for uncovering new etiologic factors and novel biomarkers to assist in identification of high-risk populations for gastric cancer, and ultimately improve disease prevention. To achieve these goals, we propose to conduct a comprehensive metabolomics study of gastric cancer risk with a multi-center, nested case-control design within a new international consortium.